Ancillary Study to the TRUST Trial: Coronary Dual-Energy CT for the Resolution of Coronary Monosodium Urate Deposits with Urate-Lowering Therapy (TRUST CORODECT)

ABSTRACT: Gout is the most common inflammatory arthritis worldwide caused by the deposition of
monosodium urate (MSU) crystals. The disease burden of gout is high and continues to rise, with >12 million
US adults being affected by gout. In addition to causing recurrent and excruciating flares of arthritis, gout is
independently associated with cardiovascular disease (CVD) and contributes to premature mortality. This
premature mortality among patients with gout persists even after adjusting for atherosclerotic CVD risk factors,
suggesting that gout-specific mechanisms contribute to premature mortality among patients with gout. One
hypothesized gout-specific mechanism is the direct deposition of MSU crystals in the vasculature, which can
activate the NLRP3 inflammasome and interleukin-1ß pathway locally; this same pathway is heavily implicated
in the pathogenesis of atherosclerotic CVD in response to cholesterol crystals. Multiple pathology and optical
coherence tomography studies have demonstrated evidence of microscopic MSU crystals in the vasculature.
Subsequently, there has been surging interest in the use of dual-energy computed tomography (DECT) for the
non-invasive identification of macroscopic MSU crystals in the vasculature.
Building on this interest, and our recent multi-center cross-sectional coronary DECT study
(CORODECT) in which we found that patients with gout had 2.7-fold higher odds of having DECT findings
consistent with vascular MSU deposition compared to controls, we propose to conduct the first-ever
longitudinal study to determine if effective urate-lowering therapy leads to the reduction in these vascular MSU
lesions. This imaging study will be ancillary to the multi-center Treat-to-Target Serum Urate versus Treat-to-
Avoid Symptoms in Gout: A Randomized Controlled Trial (TRUST; U01 AR080985). In this time-sensitive
proposal, we will obtain DECT scans of the coronary arteries and bilateral feet at baseline and month 18
among TRUST participants (all with serum urate ≥6 mg/dL) randomized to treat-to-target serum urate (TTT-SU,
intensive urate-lowering) versus treat-to-avoid-symptoms (TTASx, symptom-focused management). Aim 1 will
assess whether TTT-SU is associated with greater reductions in vascular MSU deposit volumes and numbers
than TTASx over 18 months (we hypothesize TTT-SU will be more effective), whilst Aim 2 will assess the
correlations between baseline MSU volumes in the feet and vasculature, and correlations in changes in MSU
volumes at these sites. TRUST provides an unparalleled opportunity to conduct a longitudinal DECT study
among patients with well-phenotyped gout recruited from primary care practices, taking full advantage of the
randomization of the intervention, to fill a critical evidence gap in our understanding of the role of vascular MSU
deposits as a gout-specific mechanism contributing to CVD and premature mortality. The anticipated findings
will provide compelling rationale and immediately actionable evidence for the use of ULT as a cardioprotective
intervention among patients with gout.

Public health relevance
PROJECT NARRATIVE In this time-sensitive dual-energy CT imaging study, we propose to examine the resolution of vascular monosodium urate (MSU) deposits among patients with inadequately treated gout who receive intensive urate- lowering therapy versus symptom-focused management for gout. This is an ancillary study to the Treat-to- Target Serum Urate versus Treat-to-Avoid Symptoms in Gout: A Randomized Controlled Trial (TRUST) (U01 AR080985). This proposal will fill a critical evidence gap in our understanding of the role of vascular MSU deposits as a gout-specific mechanism contributing to cardiovascular disease and premature mortality among patients with gout.